Mechanistic studies of hirsutinolides and azetidine based small molecule inhibitors of STAT3

Project Summary/Abstract
Triple-negative breast cancer (TNBC) is generally treated with chemotherapy, which only achieves incomplete
response. Relapsed disease has no new treatment options, and the long-term outcomes are poor. The central
premise of our proposal is that the TNBC’s survival dependency on high glucose-6-phosphate dehydrogenase
(G6PD) and thioredoxin reductase 1 (TrxR1) functions, elevated NADPH and GSH levels, and aberrantly active
signal transducer and activator of transcription (STAT3), which are adaptation mechanisms, makes them
therapeutically vulnerable to two chemotypes: R001, R002, and H182, H333. R001/R002 (natural products)
moderated the high G6PD, TrxR1, and STAT3 functions, thereby decreased GSH levels, and induced gene
expression changes, while H182/H333 (azetidine-based) potently and selectively inhibited STAT3 activity and
gene expression in TNBC cells. The collective inhibition of the high G6PD, TrxR1, STAT3 and GSH functions
and gene expression changes led to reactive oxygen species (ROS) build-up in TNBC cells, DNA damage, cell
cycle arrests, cell death, and tumor growth inhibition in vivo of TNBC models. Though indeed, G6PD, TrxR1 or
STAT3 knockdown alone led to ROS build up in TNBC cells, and RNAseq profiling showed STAT3 inhibition
alone led to enrichment for the genes in the DNA damage, ER stress response, UPR, and senescence pathways
in H182-treated TNBC cells, we anticipate differences between the chemotypes’ activities, which we seek to
define to better tailor these compounds for TNBC treatment. Normal cells, which have low background G6PD,
TrxR1, NADPH, GSH, and STAT3 functions are unaffected. We hypothesize that the moderation of the
redox/metabolic events and gene regulation through the targeting of G6PD, TrxR1, and STAT3 by R001, R002,
H182 and H333 inhibits TNBC growth. We further hypothesize that the compounds’ effects on the metabolic,
redox and STAT3 pathways in non-tumor cells in the TME contribute to the antitumor response. We will define
the differences between the chemotypes. 1. Investigate the interactions of STAT3, G6PD, and TrxR1 with the
compounds in vitro to define their inhibition modes; 2. Study how the specific targeting of STAT3 by the azetidines
and the modulation of G6PD, TrxR1 and STAT3 functions by natural products differ in the downstream changes
in glycolysis and pentose phosphate pathway (PPP) that feed into NADPH and GSH levels and in gene
expression in vitro and in vivo; 3. Investigate ROS induction and the associated stress response, DNA damage,
cell cycle changes and cell death, their molecular regulators, including oxidoreductases in TNBC cells and tumor
tissues following treatment; and 4. Investigate the antitumor responses to the inhibitors in vivo in CDX, PDX,
4T1/Balb-c, and E0771/BL6 models. We will gain new, indept insights into TNBC’s dependence on dysregulated
G6PD, TrxR1 NADPH, GSH and STAT3 functions and the preferential effects of inhibitors. X-ray crystallographic
studies will give atomic level details into the direct interactions. The successful development of R001, R002 or
H182, H333 and their combination therapy with ICI will provide a novel effective treatment for TNBC.

Public health relevance
Project Narrative We will gain new, indept insights into TNBC’s dependence on dysregulated G6PD, TrxR1 NADPH, GSH and STAT3 functions and the preferential effects of inhibitors. X-ray crystallographic studies will give atomic level details into the direct interactions. The successful development of R001, R002 or H182, H333 and their combination therapy with ICI will provide a novel effective treatment for TNBC.